Targeting the VHR phosphatase for the treatment of sepsis in COVID-19 patients

PROJECT SUMMARY
Recent studies have demonstrated that severe or critically ill coronavirus disease 2019 (COVID-19) patients
develop typical clinical manifestations of sepsis and septic shock, serious medical condition characterized by
dysregulated systemic inflammation and excessive release of proinflammatory cytokines. The cytokine storm is
followed by immunosuppression, ultimately leading to tissue damage, organ failure, and often death. Effective
treatment options for sepsis and septic shock are limited, and the mortality rate is extremely high with up to 50%
for sepsis and up to 80% for septic shock. The dual-specificity phosphatase 3 (DUSP3), also known as Vaccinia-
H1-related phosphatase (VHR), is highly expressed in monocytes and macrophages and plays a critical role as
a positive regulator of the innate immune response. Genetic deletion of VHR confers strong protection against
endotoxin shock and polymicrobial septic shock. VHR-/- mice are resistant to inflammatory shock induced by
lipopolysaccharides (LPS) and cecum ligation and puncture (CLP)-induced sepsis. This protection is associated
with decreased systemic production of proinflammatory cytokines such as TNF and IL-6, which are elevated in
COVID-19 patients. Based on these findings, inhibition of VHR with small molecule inhibitors may be beneficial
for the treatment of sepsis and septic shock, which are responsible for the majority of COVID-19 deaths.
Importantly, VHR knockout mice are healthy, fertile, and show no spontaneous phenotypic abnormalities,
suggesting that specific drugs targeting VHR may have no deleterious side effects. We previously reported a
VHR small molecule inhibitor, MLS-0437605, with good potency and selectivity. We propose to optimize this
compound for in vivo studies in the CLP mouse model of septic shock. Success in generating a specific VHR
inhibitor that protects mice from septic shock in the CLP model will prompt additional preclinical development
towards a clinical candidate in future studies. To achieve these objectives, our aims are to 1) define the allosteric
binding site in VHR targeted by MLS-0437605, and 2) to optimize the potency, selectivity, and drug-like
properties of MLS-0437605, and to assess the efficacy of optimized compounds in cellular and in vivo models.
This proposal leverages the expertise of an established and well-functioning team that has been collaborating
on several phosphatase drug discovery projects in the past.

Public health relevance
PROJECT NARRATIVE The majority of severely ill coronavirus disease 2019 (COVID-19) patients develop typical clinical symptoms of sepsis and septic shock, critical medical conditions that lack treatment options and often lead to death. We propose to develop a novel therapeutic strategy based on small molecule inhibitors of the dual-specificity phosphatase VHR, a critical regulator of the innate immune response whose deletion confers strong protection against sepsis and septic shock.